Stem Cell-Derived Microfluidic Placenta Organoids

Project Summary
The placenta performs important functions to ensure proper development of the fetus, including oxygen and
nutrients exchange, waste product removal and hormone secretion. It also acts as a barrier to protect the fetus
from harmful substances and pathogens that might be present in the maternal circulation. Despite its short
lifespan, the placenta plays a critical role in the survival and growth of the fetus. Implantation failure and
inadequate placental development can lead to pregnancy complications, such as preeclampsia, miscarriage,
and fetal growth restriction. However, our understanding of human placenta development is quite limited due to
scarcity of fetal tissues, ethical restrictions and lack of practical experimental tools.
Our preliminary studies show that human trophoblast stem cells (hTSCs) possess an intrinsic self-
organization property. When a colony of hTSCs starts to cluster, they spontaneously form an organoid with
cavities resembling trophoblastic lacunae, and can continuously develop into a multicellular tissue resembling
first-trimester placental villi under a neuregulin 1 (NRG1) stimulation. In this proposed research, we will
undertake an exploratory, high-risk but high-reward study to generate a microfluidic human placenta model.
Specifically, we will derive hTSCs from human induced pluripotent stem cells (hiPSCs) through a naïve
pluripotency stage. We will then use these hTSCs to generate microfluidic placenta organoids. The role of YAP
signaling in regulating spontaneous syncytiotrophoblast (STB) differentiation will be examined. We will further
induce the development of placental villus-like tissue by modulating timing and concentration of NRG1, and
examine morphologies and cell composition of the resultant placenta organoids. Important, we will conduct
single-cell RNA sequencing (scRNA-seq) analysis on the resultant placental villus-like tissue at different times
and perform transcriptome-wide comparisons with published in vivo human placenta scRNA-seq datasets.
This hTSC- derived human placenta organoid system will offer the first-of-its-kind experimental platform
for studying previously elusive stages of human placental development. This research, if successful, will lead
to innovative technologies and methodologies for controllable, reproducible, and scalable manufacturing of in
vitro stem cell-derived tissues with molecular and cellular characteristics consistent with the early/mid-gestation
placenta. This platform can also serve as a screening tool to investigate the potential negative effects of
pathogens, drugs or toxic substances on human placental development, which will accelerate research efforts
towards early diagnosis, prevention and treatment of pregnancy complications associated with insufficient or
abnormal placentation.

Public health relevance
Public Health Relevance Statement Despite its crucial role in the survival and growth of the fetus, our understanding of human placental development is quite limited due to the lack of practical experimental tools. The recent discovery of trophoblast differentiation potential of pluripotent stem cells offers great promise for filling this knowledge gap. In this R21 project, we will undertake an exploratory, high-risk but high-reward study to generate microfluidic placenta organoids using human induced pluripotent stem cells. This platform will facilitate the study of placental development and aid in the development of screening platforms for the diagnosis, prevention, and treatment of placenta dysfunction.